Restoration of ependymal integrity reduces posthemorrhagic hydrocephalus in preterm neonates

Abstract
About 27% of premature infants weighing less than 1500 g develop intraventricular hemorrhage (IVH). These
infants suffer from post-hemorrhagic hydrocephalus, cerebral palsy, and cognitive deficits. No optimal therapy
exists to prevent or minimize post-IVH hydrocephalus. IVH damages the multiciliated ependyma in the cerebral
ventricles and aqueduct disrupting the cilia-driven CSF flow. Moreover, this inflames the choroid plexus (ChP)
and periventricular regions, increasing CSF production and contributing to hydrocephalus. The cerebral ventricle
in fetuses is lined by pseudostratified epithelium consisting of radial glia and other neural progenitors. As the
brain matures, the radial glia differentiates into multiciliated ependymal cells (E1) and quiescent neural stem
cells (B1). This multiciliated differentiation program is regulated by MCIDAS>p73>FOXJ1 signaling pathway that
regulates the specification of radial glia into multiciliated ependyma. Indeed, human infants with FoxJ1 or
MCIDAS mutation and FoxJ1 knock-out mice display defective multiciliated ependyma and hydrocephalus. IVH
injures the ependyma and ChP, reduces the proliferation of progenitors in the ventricular (VZ) and subventricular
zone (SVZ), and downregulates Sonic hedgehog (Shh) expression in the periventricular regions. Conversely,
Shh overexpression promotes the proliferation of progenitors in VZ and SVZ, reduces inflammation, and
upregulates FoxJ1, p73, and Rfx3 transcription factors, likely promoting repair of the damaged ependyma and
CSF flow. Our preliminary data show that IVH reduces the number of E1 and B1 cells. Additionally, the Shh
activation increases the population of E1 and B1 cells and reduces the ventricular volume in the rabbit model of
IVH. We hypothesize that a) IVH results in apoptosis, reduction, and arrested maturation of multiciliated
ependymal cells in preterm rabbits and humans, and b) activation of Shh/MCIDAS > FoxJ1 signaling reverses
the damage to the ciliated ependyma and reduces hydrocephalus in kits with IVH. Our well-established rabbit
model of IVH (E29 kits) and autopsy samples from human preterm infants will be used to test these hypotheses.
In Aim 1, we will evaluate the effect of IVH on the proliferation and maturation of the ependyma development in
premature rabbit kits (E29) at postnatal D3, 7, and 14 by immunohistochemistry and electron microscopy. Also,
the planar polarity of cilia in immunostained sections, ciliary movement, and ependymal transcriptomic changes
by scRNA-seq will be assessed. Autopsy samples from human fetuses and premature infants (20-40 weeks) will
be analyzed to assess the impact of gestational age and IVH on the ciliated ependyma development. In Aim 2,
we will determine if Shh activation by Ad-Shh or Smo-agonist treatment reverses IVH-induced ependymal
damage, ciliary loss, hydrocephalus, and behavioral deficits by increasing FoxJ1 expression. In Aim 3, we will
modulate MCIDAS>p73>FoxJ1 signaling to reverse the ependymal injury, reduce hydrocephalus, and assess
its impact on Shh-signaling. These studies should hasten the development of new therapies for hydrocephalus
and expand our understanding of ependymal plasticity in premature newborns.

Public health relevance
Project Narrative Brain ventricle is lined by specialized cells known as ependyma, which bears dozens of motile cilia. Ciliary beating contributes to the flow of cerebrospinal fluid. In the proposed study, we will determine whether occurrence of intraventricular hemorrhage (IVH) disrupts the development of ependyma and motile cilia and if so, how this can reversed to restore CSF flow and prevent hydrocephalus in the premature newborns with IVH. This research is relevant to public health because discovery of mechanisms by which IVH contributes to hydrocephalus will lead to interventions to prevent this disorder.